Clinical Site Monitoring Group - Immune Tolerance Network - for Clinical trials

The Clinical Site Monitoring Group contract will provide clinical site monitoring support services for the Immune Tolerance Network, which conducts clinical trials and performs clinical research studies.